MATHEMATICAL MODELING OF COCHLEAR MECHANICS

The processes within the cochlea which enable it to achieve its high sensitivity and sharp frequency selectivity are still largely unknown. The primary goal of the research proposed here is to improve our understanding of cochlear function by developing a realistic mathematical model of cochlear mechanics. This model development will involve the formulation of hypotheses concerning cochlear function which will be tested by comparing numerical solutions of the model with experimental observations published by other researchers. Among the major objectives are: 1) an investigation of the possible role that active elements within the cochlea may play in boosting the sensitivity and frequency selectivity and frequency selectivity of basilar membrane displacements; and 2) a description of the changes in model parameters that correlate with common hearing impairments or normal developmental gradients. A secondary goal of the proposed research is the development of computer algorithms which simulate the frequency analysis of the cochlea and are fast enough to be considered for use in applications such as speech spectrograms or cochlear implant prostheses.